Arkansas Department of Health's Rapid Response Team Building Project

Arkansas Department of Health's Rapid Response Team (RRT)
Project Summary
Currently the Arkansas Department of Health's (ADH) Wholesale/Manufactured Foods
Program (WMFP) in the Food Protection Section of the Environmental Health Branch
has been operational and functioning since 2013. We do not have a Rapid Response
Team (RRT).
This proposal will ensure continued development of our WMFP and provide the
foundation for the development of a Rapid Response Team as well as further expand
our efforts in protecting and improving the health and well-being of Arkansans.
Recently, our program was contacted by our sister agency, the Arkansas Department of
Agriculture - Plant Industries Division, Produce Safety Program, concerning produce
safety response for their program. That agency has provided us with a letter of support
as there is a need for all regulatory partners – state, federal and academia to quickly
respond if there was a food hazard incident in our state.
The ADH mission is to protect and improve the health and well-being of all Arkansans.
Building an IFSS and establishing a mutual reliance with federal and state partners will
support the ADH mission. With continued FDA support, the Arkansas WMFP can
continue to improve food safety within Arkansas and prepare for unexpected food
incidents that could potentially extend beyond stateliness in the future.

Public health relevance
Arkansas Department of Health's Rapid Response Team Building Project (RRT) Project Narrative The Arkansas Department of Health is submitting an application for three years development funding for a Rapid Response Team (RRT). The total amount of the funds requested for the project is $524,066.17. Funds will support a full-time RRT coordinator, training, travel, and all associated support for developing a RRT.